Designing and Testing a Large Language Model-Based Cognitive Processing Therapy Worksheet Helper

Project Summary
The goal of the proposed exploratory project is to refine and test a generative artificial intelligence (AI)-based
Cognitive Processing Therapy (CPT) Worksheet Helper. The development phase follows a user-centered
design approach to generate qualitative (e.g., user experience) and quantitative (e.g., feasibility, usability)
feedback about iterative versions of the AI Worksheet Helper from patients (n=10), therapists (n=10), and CPT
experts (n=3). In addition to refining the tool itself so that it can engage CPT mechanisms, feedback will be
elicited about how the AI Worksheet Helper can be most effectively integrated into CPT to support homework.
CPT+AI Worksheet Helper will then be compared to CPT+CPT Coach in 50 individuals with PTSD using a pilot
effectiveness randomized controlled trial (RCT). Aim 1 (Discover/Design/Build): Develop a generative AI-based
Worksheet Helper using a user-centered design approach that collects and iteratively integrates qualitative and
quantitative feedback from patients, therapists, and CPT experts. Aim 1a Discover/Design: Develop and refine
the AI Worksheet Helper via iterative patient feedback about the tool’s functionality, design, and usefulness via
focus groups and in-depth individual user-design sessions. Aim 1b Discover/Design: Gather qualitative and
quantitative therapist feedback about the AI Worksheet Helper’s functionality, design, and requirements to
seamlessly integrate into and potentially enhance CPT’s effectiveness. Aim 1c Build: Integrate user feedback
and work collaboratively with CPT experts to ensure the AI Worksheet Helper facilitates core therapeutic
components. Aim 2 (Test): Evaluate the feasibility and acceptability of the AI Worksheet Helper in the context
of treatment as part of a pilot RCT design (N=50). Aim 2a: Evaluate enrolled CPT + AI Worksheet Helper
patients’ (n=25) satisfaction with the tool during and between sessions, and the perceived helpfulness for
learning skills and reducing PTSD symptoms using a mixed-method approach. Aim 2b: Qualitatively and
quantitatively evaluate study (routine care) therapists’ perceived usefulness of the tool and its ability to facilitate
engagement, skill development, and worksheet completion. Aim 3 (Test): Determine the AI Worksheet Helper’s
initial effectiveness for improving treatment completion and engage previously hypothesized treatment
mechanisms (i.e., trauma cognition changes, homework completion, and self-efficacy) using a pilot RCT
design (N=50). Aim 3a (Outcomes): Evaluate whether the CPT + AI Worksheet Helper produces greater
treatment completion, session attendance. Aim 3b (Mechanisms): Determine whether the tool can facilitate
active learning, and produce greater behavioral intention, homework completion and quality, trauma cognition,
and self-efficacy change than CPT+CPT Coach. Aim 3c (Predictors): Test whether AI Worksheet Helper
engagement is associated with outcomes and mechanisms engagement. Data will support a larger trial to
determine the AI Worksheet Helper's ability to engage treatment mechanisms and reduce symptoms.